Clinical Translation and Validation Core

Project Summary / Abstract
The Clinical Translation and Validation Core of the Atlanta Center for Microsystems Engineered Point-
of-Care Technologies (ACME POCT) will be a central feature of the Center's mission to translate POC device
development through human subject validation studies. The Clinical Translation and Validation Core will
provide an extensive clinical testing environment, necessary clinical validation testing expertise and
infrastructure, guidance in study design, ethics and regulatory compliance, data collection instruments and
data management, statistical analysis, creation and maintenance of a POC technology and clinical expertise
database, and promotion of scientific interchange between projects and externally to collaborators and
programs outside of Emory University and Georgia Tech through the Technology Development/Refinement
Core and the Technology Training and Dissemination Core. The mission of the Clinical Translation and
Validation Core is to facilitate the successful conduct of human subjects clinical validation studies of POC
devices, develop and maintain clinical content experts available to facilitate testing in a consortium of testing
sites, and develop and maintain a database of POC opportunities related to heart, lung, blood and sleep
disorders. Achieving this mission will promote the mission of the POC Network to address unmet clinical needs
in point-of-care testing, monitoring and treatment and favorably impact our nation's health.